NONINVASIVE DETERMINATION OF AUTONOMIC REGULATION OF HEART RATE VARIATION

The purpose of this study is to use spectral frequency analysis of heart rate variation to determine the contributions of the sympathetic vs. parasympathetic nervous system. Another goal is to determine age-related changes in heart rate variation and the role of the autonomic nervous system in modulating these changes. In addition, AV conduction measures will also be determined.